Research Opportunities in Comparative Medicine

Project Summary
The long-term goals and objectives of the Stanford University T35 program is to develop and
enhance training opportunities for veterinary students interested in careers in biomedical,
behavioral, and clinical research. The program will continue to provide intensive, short-term
research training experiences for veterinary students from across the country that come to
Stanford University for the summer. Each summer, eight first- through third-year veterinary
students will be supported by the NIH and up to two more students will be supported by
Stanford University. Students will spend 12 weeks at Stanford training in basic, behavioral, or
clinical research aspects of the health-related sciences. Key elements of the research
training plan include a mentored research project in a well funded and productive laboratory,
research-related workshops, a journal club, research presentations, career development
sessions with veterinarians who are at different levels of career development and that
contribute to research in diverse ways, and research presentations at Stanford University and
at the Merial-NIH National Veterinary Scholars Symposium. The program will encourage
veterinary students to pursue research careers by exposure to and short-term involvement in
the health-related sciences. Training will be of sufficient depth to enable students, upon
completion of the program, to have a thorough exposure to the principles underlying the
conduct of research. The program is designed to help veterinary students develop careers
that will exert a sustained, powerful influence on biomedical, behavioral, and clinical research.

Public health relevance
Project Narrative The United States needs more veterinary researchers. This program's primary objective is to help veterinary students develop research careers. The long-term effect of this program, and others like it, is strengthening of the nation's workforce in laboratory animal medicine, comparative pathology, and comparative medicine.